Intermountain PREP

PROJECT SUMMARY / ABSTRACT
The mission of the Intermountain PREP (IM-PREP) is to build a diverse biomedical research workforce reflecting
the talent pool of our diverse population. The University of Utah is committed to fortifying, sustaining, and
amplifying the STEM pipeline that trains and launches a diverse research workforce. IM-PREP will specifically
address the leaks in the pipeline leading from undergraduate to doctoral training of groups underrepresented in
STEM. IM-PREP will recruit students from diverse backgrounds, including pipeline relationships with Historically
Black Colleges and Universities. These students demonstrate a strong drive for research and would benefit from
additional research-intensive training experiences and professional development, enhancing both their
successful transition to top-tier doctoral programs, as well as their long-term retention in PhD-based career
tracks. In order to accomplish these goals, IM-PREP will provide key proposed activities that include (1) holistic,
culturally-competent mentored experiences to undertake hypothesis-driven research; (2) scientific coursework
and professional workshops that enhance strong oral and written communication skills, and instill successful
strategies for applying to graduate school; (3) an innovative, inclusive support system that develops and
implements an Individual Development Plan (IDP), in a mastery learning context, to enhance trainee self-efficacy
and authentic scientific identity. Throughout the training process, we employ a matrix mentoring approach that
incorporates peer and near-peer support, cultural STEM communities and diverse role-models. Our approach is
built on University-wide momentum and infrastructure dedicated to supporting STEM equity, diversity and
inclusion. As part of its institutional commitment, the University of Utah funded a pilot IM-PREP program
beginning last spring, and we have shaped our proposed extramural program based on practical experience
developing and leading the IM-PREP pilot and mentoring its diverse trainees. We are confident that IM-PREP
will fortify its Scholars’ critical thinking and research mastery and develop a resilient mindset to persist in graduate
training and beyond, where they will join and lead a more diverse biomedical research enterprise.

Public health relevance
PROJECT NARRATIVE A national challenge in the biomedical sciences is to recruit, train, and retain the broadest and most diverse scientific talent pool possible. At the University of Utah, we are poised to tackle this challenge by leveraging our recent successes in recruiting underrepresented students into our graduate programs and redoubling our efforts on the postbaccalaureate population. We will establish the Intermountain Postbaccalaureate Research Education Program and solidify key relationships with our local community and Historically Black Colleges and Universities to foster an inclusive, research-intensive environment where underrepresented scientists can flourish and attain their goal of admission to top-notch PhD training programs.